Epithelial glycocalyx degradation mediates surfactant dysfunction in acute respiratory distress syndrome

PROJECT SUMMARY/ABSTRACT
Acute respiratory distress syndrome (ARDS), a common cause of respiratory failure in the ICU, is characterized
by surfactant dysfunction and impaired lung compliance. Our preliminary data demonstrate that the alveolar
epithelial glycocalyx, a layer of glycosaminoglycans that coat the apical surface of the epithelial cells, is damaged
in multiple different murine models of ARDS. Additionally, we found that specific enzymatic degradation of the
epithelial glycocalyx is sufficient to cause decreased lung compliance and microatelectasis, which appears to be
mediated by impaired surfactant function. We have also translated these findings to humans using noninvasively
collected airspace fluid obtained from heat moisture exchange filters, which are devices that are used to humidify
the airways as part of the usual care of mechanically ventilated patients. Excitingly, we demonstrated that
alveolar epithelial glycocalyx degradation, measured by levels of glycosaminoglycans in the airspace fluid, is
predictive of duration of mechanical ventilation and degree of hypoxemia. In this proposal, we will determine
the mechanisms by which epithelial glycocalyx degradation causes surfactant dysfunction and confirm
the translational relevance of these findings in human ARDS patients using noninvasively collected
airspace fluid. In Specific Aim 1, we will identify the surfactant protein that binds to the epithelial glycocalyx
using heparin affinity chromatography conducted on mouse bronchoalveolar lavage fluid. We will then utilize a
heparan sulfate glycoarray to identify the specific heparan sulfate oligosaccharide fragment responsible for this
interaction. The functional importance of this interaction will then be tested in mice by administering chemically
synthesized surfactant protein-binding oligosaccharides (to competitively displace surfactant from the native
alveolar epithelial glycocalyx) and measuring the effects on lung structure and function using design-based
stereology, lung mechanics measurements, and constrained sessile drop surfactometry. In Specific Aim 2, we
will conduct a pilot observational clinical study in which we will collect both heat moisture exchange filters and
advanced lung mechanics data (peak pressure, plateau pressure, driving pressure) from the ventilators of ARDS
patients. We will then use this data to test our hypothesis that the quantity of glycosaminoglycans shed into the
airspace, measured using a novel point-of-care assay (dimethylmethylene blue), is inversely related to lung
compliance in ARDS patients. Given that there are currently no available clinical tests that can predict the course
of ARDS, these findings have the potential to become rapidly impactful to patient care in the ICU. This research
will be carried out in the highly collaborative Division of Pulmonary Sciences and Critical Care Medicine at the
University of Colorado and Denver Health Medical Center. We anticipate that this project will generate data that
will both advance the field of translational ARDS research and serve as the foundation for my K08 award
application and eventual transition to independent investigator status.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS) is a common cause of respiratory failure in the intensive care unit. Our preliminary data demonstrate that damage to the epithelial glycocalyx (a complex layer of sugar molecules that lines the airways) is a critical step in the development of this disease. The proposed research aims to (1) determine how damage to this structure contributes to ARDS and (2) develop a method to noninvasively measure damage to this structure in patients.